Predicting glymphatic function via PET/MR imaging biomarkers and Nose to Brain contrast delivery

PROJECT TITLE: Predicting glymphatic function via PET/MR imaging biomarkers and Nose to Brain
contrast delivery
PROJECT ABSTRACT: The recently identified glymphatic system, which modulates exchange of the brain’s
interstitial fluid and cerebrospinal fluid, has been shown to play a major role in the clearance of waste products
from the brain. Individuals with dementia or old age show diminished glymphatic clearance, which is
hypothesized to contribute to protein aggregation, neurotoxicity, and cognitive decline. The impact of changes
in glymphatic function have not been comprehensively investigated, as clinical methods to evaluate the
glymphatic system are lacking. A sensitive and noninvasive imaging tool for evaluation of glymphatic function is
clearly needed. This proposal addresses this need by testing sensitive, non-invasive methods for quantifying
brain waste clearance that are readily translatable to the clinic. Nose to brain (N2B) delivery is a useful tool for
direct delivery to the brain and is hypothesized to utilize glymphatic vessels for distribution throughout the brain
tissue. We will test whether N2B PET tracer clearance from the brain visualized by noninvasive PET/MRI
provides meaningful information about glymphatic function, and correlate with known anatomical changes by
fluorescence microscopy. Our PET approach will be compared to the MRI current gold standard for glymphatic
imaging and tested in physical and pathological models of glymphatic alterations. If successful, this study could
provide a tool for early detection of diminished glymphatic function before the onset of neurotoxic pathology.

Public health relevance
PROJECT NARRATIVE The goal of this project is to establish a non-invasive method for assessing reductions in waste clearance from the brain using positron emission tomography (PET) and compare to established gold-standard methods of assessing (g)lymphatic clearance via 3D T1-weighted magnetic resonance imaging (MRI). We will test whether rates of radiotracer clearance from the brain are indicative of (g)lymphatic flow rates to determine which datasets are most informative of (g)lymphatic changes in models of functional impairment. If our goals are achieved, this research will enable a quantitative imaging method to follow (g)lymphatic function using FDA-approved imaging agents and instruments for rapid translation to the clinic.